GRip Assessment for Protocol Enhancements (GRAPE) in Older Adults

PROJECT SUMMARY/ABSTRACT
Maximal handgrip strength (HGS) is considered a convenient and reliable measure of muscle function. Current
protocols for assessing HGS focus exclusively on achieving maximal grip force; however, maximal strength is
only a single characteristic of muscle function. Given that muscle function is multivariable, maximal HGS, as a
measure of muscle function, could be incomplete. Other important aspects of muscle function such as bilateral
coordination, explosiveness, submaximal force control, neuromuscular steadiness, strength asymmetry
between limbs, and resistance to fatigue are overlooked in HGS assessments. Yet, deficiencies in each of
these aspects are associated with health conditions linked to poor muscle function. Evaluating these additional
aspects of muscle function, alongside maximal HGS, could improve how we conveniently assess muscle
function and support the development of a new HGS protocol that could be utilized in clinical and translational
research settings. This may aid in the discovery of processes that better predict age-related disability and
disease, which will strengthen relevant screenings, better operationalize muscle function, and initiate
opportunities for interventions to target specific characteristics of muscle function for successful aging. This
work will advance how we assess muscle function by pursuing the following three specific aims: 1) evaluate
the correlations of hand dominance and test-retest reliability for maximal HGS, bilateral HGS coordination, rate
of HGS force development, submaximal HGS force control, neuromuscular HGS steadiness, HGS asymmetry,
and HGS fatigability in older adults; 2) determine the multivariate relationships between maximal HGS, bilateral
HGS coordination, rate of HGS force development, submaximal HGS force control, neuromuscular HGS
steadiness, HGS asymmetry, and HGS fatigability to derive one or more HGS principal components in older
adults; and 3) examine how maximal HGS, bilateral HGS coordination, rate of HGS force development,
submaximal HGS force control, neuromuscular HGS steadiness, HGS asymmetry, and HGS fatigability are
associated with knee extension strength, timed-up-and-go, short physical performance battery, gait speed, and
400-meter walk in older adults. Each HGS measure will be collected with digital handgrip dynamometers and
accelerometers. Participants will also complete physical performance measurements to determine the study
outcomes. This work has the potential to fundamentally transform clinical practice by better identifying the
onset and progression of the disabling process with a new muscle function assessment. Our contribution is
innovative because it could reveal that other characteristics of muscle function, when examined in HGS
protocols, may not be related to maximal HGS and thereby could be more robustly associated with clinically
relevant health outcomes. Ultimately, this research could improve the prognostic utility of muscle function
assessments in clinical and translational research settings for preventing age-related disability and disease.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because the changes in muscle function that occur during aging increase the risk of age-related disease and disability. Our current muscle function assessments could be incomplete and fail to efficiently detect future health problems. Improving how we assess muscle function will help us better prevent and treat age-related health conditions.